Lipid Signaling in Chemotaxis

Summary Through the funding opportunity described in PAR-18-591, this proposal seeks funds to purchase a Amersham Typhoon FLA Phosphoimager. The goals of the propose study are to investigate how cells sense extracellular chemical gradients and control their migration behaviors. The Specific Aims of the parent grant focus on the mechanisms that stabilize directional sensing, link PIP3-binding myosin I to cytoskeletal reorganization and recruit PTEN to the plasma membrane.

Public health relevance
Narrative Chemotaxis has been linked to many human diseases such as cancer, asthma, arthritis and atherosclerosis. The proposed research projects will deepen our understanding of the molecular mechanism of chemotaxis and the pathogenesis of the chemotaxis-related diseases using genetics, biochemistry and cell biology.